MnSOD-K68-Ac reprograms a lineage plasticity switch / stemness in ER+ breast malignancies.

Summary - A fundamental theme in personalized cancer medicine is to identify specific subgroups
of patients, based on molecular biomarkers and/or tumor signatures, which will subsequently benefit
from new therapeutic strategies, including targeted agents. An important, and longstanding, example
of this concept is the dependency of a subgroup of breast malignancies on the estrogen receptor
(ER) as well as the ER signaling axis. In this regard, there is a subgroup of women with ER+ luminal
B human breast malignancies that exhibit a significant risk of recurrence due to the development of
resistance to endocrine therapy, including Tamoxifen. To address this, there is an ongoing search
to define the pathways or molecular mechanism(s) leading to the resistance to endocrine therapy. A
second significant theme in cancer medicine is based on the idea of “oncogene addiction”, a
phenomenon that implies while tumors contain multiple genetic, epigenetic, signaling, and metabolic
abnormalities and despite this tumor complexity, cell growth and survival can often be impaired by
the targeting of a single driver gene/protein.
As such, the phenomenon of oncogene addiction
in
specific cancers, including luminal B breast carcinogenesis, provides a scientific rational to identify
carcinogenic drivers in the process luminal B resistance to endocrine therapies. Metabolic stress,
due to aberrant reactive oxygen ROS levels, is a hallmark of cancer that disrupts mitochondrial
physiology and metabolism leading to an oncogenic addition-like phenotype and resistance to
endocrine therapy. Based on these observations, it is proposed that K68 acetylation (K68-Ac)
promotes a newly discovered monomeric form of MnSOD, distinct from the established ROS
detoxification role of tetrameric MnSOD, reprograms cellular and mitochondrial metabolism leading
to oncogenic and tumor resistance phenotype. Finally, will targeting the MnSOD-K68-Ac axis, using
a chemical MnSOD mimic (GC4419), convert endocrine resistance tumors to a sensitive phenotype?

Public health relevance
Narrative This research proposal addresses the question that it is becoming increasing clear that there is a dichotomous functional role for MnSOD in tumorigenesis as well as tumor cell resistance. Specifically, MnSOD appears to function as a tumor suppressor (TS) during the early, proliferative stage of tumor initiation, yet once tumorigenesis progresses, MnSOD levels appear to positively correlate or contribute to a more aggressive tumor phenotype. In this regard, it is hypothesized that the acetylation status of K68 directs whether MnSOD functions as a protective homotetrameric detoxification complex versus a monomeric peroxidase enzyme that induces a breast tumorigenic and Tam resistance phenotype.